The genetic and non-genetic responses of chromatin to force

Project Summary / Abstract
My research program centers on defining how cellular forces impinge on chromatin dynamics, gene
regulation, and genome integrity, in part through force transduction across the nuclear envelope by the
Linker of Nucleoskeleton and Cytoskeleton (LINC) complex. In the next five years, we plan to investigate
both the genetic and non-genetic functions of chromatin with the goal of revealing new insights into the
mechanics of chromosomes, the emergent biophysical properties of nuclei, and the mechanisms that
underlie nuclear mechanotransduction. As we previously demonstrated the key role that chromatin plays in
dictating the emergent mechanical properties of the nucleus, one major focus will be on examining the non-
genetic role that the epigenome plays in defining nuclear mechanics. Although altered epigenetic histone
modifications are tied to numerous diseases, the potential contribution of these changes to nuclear
mechanics is largely unstudied. We will take both targeted and open approaches to leverage our unique
tools to assess nuclear mechanics to make fundamental discoveries on this topic. While the attributes of
chromatin within the nucleus impacts the nuclear force response, exerting forces on chromatin likely also
changes its properties and/or function. We plan to take on two major challenges in this area. First, taking
advantage of the tools available in the fission yeast S. pombe, we will define an important biophysical
parameter, the genomic distance over which forces can be propagated along a chromosome, represented
by the persistence length, or bending rigidity, of chromatin in vivo. Our experiments to date strongly suggest
that literature values for chromatin persistence length, largely derived from in vitro studies or relying on
simulations, cannot explain the extent to which force can be propagated down the chromosome in living
cells. Defining this parameter is not only critical for simulations and the interpretation of experimental data in
the chromatin biology field, but is also essential for the study of nuclear mechanotransduction – the process
by which forces are translated into gene expression changes. This fundamental line of questioning will
position us to take on a second key challenge in the field: defining the contexts and mechanisms by which
forces on LINC complexes influence the transcriptome. We will continue to leverage cell lines and mouse
models lacking the SUN protein components of LINC complexes to rigorously define genetic targets of
direct force transmission and to begin to tackle the black box of the translation of force into gene expression
changes. Taken together, this proposed research program will position us to make critical and long-lasting
contributions to the field of nuclear mechanobiology.

Public health relevance
Narrative Chromatin, the DNA and its associated proteins, underlies the genetic blueprint of the cell, but can also serve in a non-genetic capacity as a material that impinges on the mechanical properties of the nucleus in which it is housed. This proposal seeks to define the mechanisms by which modulation of chromatin state influences nuclear mechanics, establish the extent to which forces exerted on chromatin are propagated along the chromatin polymer, and identify biologically-relevant, force-modulated genes for mechanistic study.